Development of an HIV-1 entry inhibitor pre-drug as a microbicide

DESCRIPTION (provided by applicant): With no vaccine in sight, there is an urgent public health need to develop an effective topical microbicide that can reduce the number of new HIV-1 infections in women. The potential role of virus-cell fusion inhibitor-based microbicides in preventing mucosal transmission of HIV-1 has been clearly identified. However, none of the reported gp41 fusion inhibitors has made significant progress toward clinical trials. HIV-1 infection requires fusion of the viral and cellular membranes, driven by association of two heptad-repeat regions in the gp41 ectodomain to form a highly stable six-helix bundle structure. Whereas this postfusion motif comprising native N36 and C34 peptides has no inhibitory activity, the isolated peptides inhibit HIV-1 entry by binding to their cognate sites on gp41. Our goal in this MIP VI application is to develop an inexpensive, potent, structured 'pro- drug' form of the N- and C-peptide fusion inhibitors that exhibits significant microbicidal activity upon use in situ. Our development effort will be based on preliminary data obtained with a truncated six-helix bundle that inhibits in vitro infection by primary HIV-1 isolates with low nanomolar IC50 values. We propose a comprehensive, interdisciplinary approach that combines high-resolution structural determination, recombinant protein production and mutagenic analyses, virology, and animal model efficacy studies. In this project we seek to conduct in vitro and in vivo preclinical and animal model-based research intended to facilitate the development of new HIV-1 gp41 peptide fusion inhibitor as a practical microbicide. The Specific Aims are: 1. To optimize and identify HIV-1 peptide fusion inhibitors for development as a vaginal microbicide. (a) To identify and incorporate specific amino-acid residue substitutions that optimize both potency and solubility of fusion inhibitor peptides. (b) To develop and optimize robust procedures for the large-scale bacterial expression and purification of select fusion inhibitor peptides. (c) Investigate the mechanisms of resistance to peptide inhibitors so as to avoid eliciting resistance. 2. To characterize the specificity, potency and toxicity of optimized peptide fusion inhibitors and their in vitro synergistic interactions with the CCR5 inhibitor CMPD167 and the entry inhibitor BMS-378806. (a) Determine the virucidal activity of optimized fusion inhibitor peptides against a diverse set of primary HIV-1 isolates. (b) Evaluate their toxicity, immunogenicity and drug stability in the rabbit model. (c) Study antiviral synergy in vitro in order to make rational predictions for lead inhibitor combinations for in vivo efficacy testing. 3. To test the effectiveness of the fusion inhibitor peptides to protect against mucosal HIV-1 infection. (a) Characterize the specificity and potency of effective peptide inhibitors in an in vitro model of HIV-1 infection of human cervical and vaginal tissue. (b) Use the NOD/SCID-hu BLT mouse vaginal transmission model to assess the in vivo potency and breadth of activity of highly effective peptide inhibitors alone and in combination with the small-molecule CCR5 inhibitor CMPD167 and the small-molecule entry inhibitor BMS-378806. 1

Public health relevance
PUBLIC HEALTH RELEVANCE: In the absence of an effective vaccine against HIV-1, there is an urgent public health need to find alternative approaches, such as vaginally applied microbicide gels, to prevent heterosexual HIV-1 transmission. Since blocking HIV-1 entry is the first line of defense against viral infection, the HIV-1 envelope glycoprotein is a favored target for microbicide development. Several HIV-1 fusion and entry inhibitors have been shown to be effective in blocking SHIV transmission in a rhesus macaque model. The results of this project will lead to preclinical proof-of-concept for optimized fusion-inhibitory peptides as a practical microbicide. In the absence of an effective vaccine against HIV-1, there is an urgent public health need to find alternative approaches, such as vaginally applied microbicide gels, to prevent heterosexual HIV-1 transmission. Since blocking HIV-1 entry is the first line of defense against viral infection, the HIV-1 envelope glycoprotein is a favored target for microbicide development. Several HIV-1 fusion and entry inhibitors have been shown to be effective in blocking SHIV transmission in a rhesus macaque model. The results of this project will lead to preclinical proof-of-concept for optimized fusion-inhibitory peptides as a practical microbicide. __SpecificAimsTextDelimiter__ 1. Specific Aims New targets for microbicide development: Current generations of microbicide candidates have not performed well in efficacy trials. Nevertheless, there is still a consensus that synergistic inhibition of different stages of virus-cell fusion can provide a powerful benefit in formulating a mechanism-based, HIV-1-specific microbicide(s) to prevent mucosal transmission of HIV-1. Several fusion or entry inhibitors have been shown to prevent SHIV transmission to macaques after vaginal administration and challenge, either by binding to the virus or to its receptors. In this proposal we apply the results of fundamental research to the development of a new HIV-1 peptide fusion inhibitor as a practical microbicide. Entry of enveloped viruses: The envelope glycoprotein (Env) of HIV-1 plays a central role in virus transmission and pathogenesis and is an important target for antiviral intervention. HIV-1 cell recognition occurs through binding of the gp120 subunit of an Env spike to the CD4 glycoprotein. The engagement of CD4 by Env activates gp120 to bind to a chemokine coreceptor. Structural changes in the gp41 subunit are then triggered that drive membrane fusion by forming a highly stable six-helix bundle structure comprising two heptad-repeat (HR) regions in the gp41 ectodomain. Fusion inhibitory peptides: Peptides derived from these HR regions (called N- and C-peptides, respectively) potently inhibit HIV-1 entry by binding to their cognate sites on gp41, thereby preventing six-helix bundle formation. We have shown for example that the C-peptide C52L can partially protect macaques from SHIV- 162P3 infection and increase the protective capacities of the small-molecule entry inhibitors CMPD167 and BMS-378806. A fusion-blocking gp41-derived peptide is thus suitable for use in a microbicide formulation, but development of inexpensive, potent peptide inhibitors for practical application remains an elusive goal. New fusion inhibitor lead candidates: Our strategy is to present the N- and C-peptides in a structured 'pro-drug' form that is economical to manufacture on a large scale and exhibits significant microbicidal activity upon use in situ. The native six-helix bundle possesses no inhibitory activity under physiological conditions, since high temperatures are required to unfold the six-helix structure and thus expose active N- and C-peptides. Our structure-based design effort has already been successful in obtaining proof-of-concept that a truncated six- helix bundle is unfolded at physiological temperatures and so able to effectively inhibit HIV-1 entry. Molecular 'pro-drug' strategy: The structured pro-drug concept can facilitate the development of peptidic fusion inhibitors as a practical microbicide for three reasons. First, N- and C-peptides have two different targets in gp41 and have been shown to synergize when used in combination. Thus, the use of the inhibitor pro-drug can help combat the global sequence diversity of HIV-1 and minimize the transmission of resistant viruses. Second, the engineered helical bundle is expressed in bacteria and thus can be produced inexpensively. Third, for peptide-based vaginal microbicides, proteolytic activity at mucosal sites can be a major obstacle to potency and effective residence times. The structured pro-drug agent can therefore be beneficial for increasing the extent and duration of its antiviral activity at the site of virus deposition by reducing its rate of degradation. We will pursue preclinical development of our lead microbicide candidate by three inter-related Specific Aims: In the R21 phase: Aim 1. To optimize and identify HIV-1 peptide fusion inhibitors for development as a topical microbicide. (a) To identify and incorporate specific amino-acid residue substitutions that optimize both potency and solubility of fusion inhibitor peptides. (b) To develop and optimize robust procedures for the large- scale bacterial expression and purification of select fusion inhibitor peptides. (c) Investigate the mechanisms of resistance to peptide inhibitors so as to avoid eliciting resistance. In the R33 phase: Aim 2. To characterize the specificity, potency and toxicity of optimized peptide fusion inhibitors and their in vitro synergistic interactions with the CMPD167 and BMS-378806 compounds. (a) Determine the virucidal activity of optimized fusion inhibitor peptides against a diverse set of primary HIV-1 isolates. (b) Evaluate their toxicity, immunogenicity and drug stability in the rabbit model. (c) Study antiviral synergy in vitro in order to make rational predictions for lead inhibitor combinations for in vivo efficacy testing. Aim 3. To test the effectiveness of the fusion inhibitor peptides to protect against mucosal HIV-1 infection. (a) Characterize the specificity and potency of effective peptide inhibitors in an in vitro model of HIV- 1 infection of human cervical and vaginal tissue. (b) Use the NOD/SCID-hu BLT mouse vaginal transmission model to assess the in vivo potency and breadth of activity of highly effective peptide inhibitors alone and in combination with the CMPD167 and BMS-378806 compounds. 1